Real-Time Diagnosis of Life-Threatening Necrotizing Soft-Tissue Infections Using Indocyanine Green Kinetic Modeling

PROJECT SUMMARY
Necrotizing soft-tissue infections (NSTIs, a.k.a. “necrotizing fasciitis” or “flesh-eating bacteria”) are aggressive
infections that can progress rapidly from mild symptoms to sepsis, multi-organ failure, and death. NSTI cases
present with non-specific clinical, imaging, and laboratory findings, and standard-of-care techniques for NSTI
diagnosis lack sensitivity and specificity, resulting in frequent misdiagnosis and delayed care, which is the single
most important predictor of survival. Consequently, the cumulative mortality rate for patients with NSTIs is 20-
30%; a dire need exists for more accurate and rapid detection of NSTIs. Fluorescence-guided surgery is a
nascent technology seeking to improve the recognition of anatomical structures and disease processes using
fluorescent probes (fluorophores). Indocyanine green (ICG) is an FDA-approved, near-infrared fluorophore with
a >60-year safety record for vascular perfusion assessment. A distinguishing histological feature of NSTIs is
prominent blood vessel thrombosis in affected tissues. Leveraging these pro-thrombotic effects, our study group
has demonstrated in a first-in-human study (NCT04839302) that intravenous administration of ICG and
immediate fluorescence imaging reveals prominent signal deficits in NSTI-positive tissues that differentiate
significantly with increased signal seen with more common—and less virulent—infections such as cellulitis. We
seek now to evaluate this imaging technique on a broader scale and determine if our findings are consistent for
patients affected by NSTI-causing pathogens that are not endemic to our region. In this proposal, a prospective,
observational, multicenter clinical study will involve video-rate ICG fluorescence imaging of patients suspected
of having NSTIs who present to seven tertiary, Level 1 medical centers across the United States (Aim 1). Using
dynamic contrast-enhanced fluorescence imaging (DCE-FI), time profiles of ICG fluorescence intensity from
different tissue pixels/regions will be extracted and parameterized to extract first-pass kinetic features. These
DCE-FI features, which characterize tissue perfusion, will be evaluated alone and in combination with
anonymized electronic medical record data to create a DCE-FI-based clinical decision tool and a machine-
learning-based fusion (DCE FI+lab/imaging data) tool; these will be compared to identify the most accurate
means of diagnosing NSTIs (Aim 2). The best-performing tool will then be evaluated—compared to current
diagnostic tests—in a prospective observational clinical study of patients presenting to tertiary emergency
departments with findings concerning for NSTIs (Aim 3). Based on our human study, fluorescence imaging will
not delay current standard of care. To ensure data fidelity, all sites will use similar: 1) commercial fluorescence
imaging systems and accessories; and 2) validated commercial fluorescence reference phantoms. Based on our
early results, we have strong confidence that following rigorous testing, ICG DCE-FI will lead to an entirely new
methodology for rapid identification of patients with NSTIs, which will ultimately reduce patient morbidity and
improve survival.

Public health relevance
PROJECT NARRATIVE Necrotizing soft-tissue infections (NSTIs) are fast-moving and deadly, and current diagnostic testing for NSTIs has low accuracy, leading to high rates of misdiagnosis, treatment delay, and death (~30%). This revised proposal will address the dire need for more accurate and rapid identification of NSTIs using dynamic-contrast enhanced fluorescence imaging (DCE-FI) with indocyanine green, which clearly demarcates NSTI-induced superficial thrombi that are not present in less virulent infections (e.g., cellulitis) and are invisible to the eye with white light imaging. This project will leverage our NSTI study group by facilitating DCE-FI imaging at seven tertiary centers, leading to revolutionary changes in the clinical evaluation of patients with suspected NSTIs, improving diagnostic accuracy, and reducing overall mortality.